SCGE Comparative Studies Supplement

The Nonhuman Primate Testing Center supports studies that advance the genome editing field, contributing to the future translation of these technologies for the treatment of human disease. The studies proposed in this supplemental application bring together two complementary SCGE Consortium teams to advance combined in vitro and in vivo safety and efficiency testing for somatic cell genome editing. The in vitro component addresses human cells in a 3D organoid model, a rapid and high-throughput testing platform for preclinical assessments. However, the degree to which organoids can predict responses in vivo remains unclear thus this system will be integrated with the synergistic preclinical primate model to address topics of interest to regulatory agencies such as dose response, editing delivery components, safety, and potential toxicities to guide preclinical/clinical monitoring. As a prototype for proof-of-concept, studies focus on the kidney because ~20 million Americans suffer from chronic kidney disease. Kidney disease is on the rise particularly in children, a population that suffers disproportionately from genetic causes that could be targeted with genome editing. CRISPR/Cas9 editing delivered by adeno-associated virus (AAV) is proposed to introduce specific edits at the AAVS1 target locus. This is an ideal candidate because it is expressed in human and rhesus with conserved sequences. In vitro studies in human organoids will be paralleled with investigations that utilize a direct ultrasound guided intrarenal approach in young monkeys. Collectively, these studies will compare human kidney organoids with outcomes in nonhuman primates to establish a new regulatory paradigm which can be applied to a range of tissues and diseases.

Public health relevance
The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools serves the Somatic Cell Genome Editing (SCGE) community and the public by supporting studies in nonhuman primates that will advance the field. Through these efforts the Nonhuman Primate Testing Center significantly contributes to the future translation of cutting-edge technologies for the treatment of a range of rare and common human diseases. These SCGE collaborative studies will compare human kidney organoids in vitro with outcomes in nonhuman primates in vivo to establish a new way to predict the safety and efficiency of genome editing to treat kidney disease.